Mitochondrial Fidelity in Mammalian Neurons

Summary
Mitochondria are multifaceted organelles that play vital roles in a myriad of cellular functions, including energy
production, metabolism, calcium homeostasis, and cell death. It is generally accepted that a decline in
mitochondria quality is a key contributor to mitochondrial dysfunction, aging, and represents a key point of
convergence for several neurological disorders. Yet, precisely how dysfunctional mitochondria contribute to
these conditions remains elusive. Mitochondria are thought to be constantly rejuvenated via collaborative
processes of mitogenesis, fission-fusion, and multi-level quality-control mechanisms. Accordingly, the average
half-life of mitochondrial proteins in the brain has been estimated at less than 3 weeks. Recently, I identified a
discrete number of mitochondrial long-lived proteins (mt-LLPs) that last at least four months in mouse brain and
heart. These long-lived mitochondrial proteins (mt-LLPs) include OxPhos complexes and several mitochondrial
cristae associated proteins, which similarly to other architecturally stable and long-lived structures (i.e. nuclear
pore complexes) are recognized for their highly defined and elaborate ultrastructure. Therefore, we hypothesized
that the exceptional longevity of mt-LLPs could play an essential role in the long-term stabilization of the
mitochondrial cristae in long-lived, post-mitotic cells.
The goal of this research proposal is to delineate the localization of mt-LLPs within mitochondria in neurons,
examine their temporal dynamics and integration with newly synthesized proteins, and investigate their potential
contribution to mitochondrial fitness and long-term cristae stability. In Aim 1, using a combination of pulse-chase
protein labeling methods, super-resolution fluorescent imaging and mass spectrometry I propose to (1) examine
the spatio-temporal dynamics of mt-LLPs in axonal and somato-dendritic domains of primary neurons. In Aim
2, we propose to extend our analysis to include mitochondrial DNA (mtDNA) by investigating the coordination
between mt-LLPs enrichment and mtDNA longevity neurons. In Aim 3, I will investigate the mechanism(s)
involved in persistence of mt-ELLPs in neurons using genetic manipulations targeting mitochondrial cristae
stability. Lastly, in Aim 4 we will begin the investigation into the coordination between nuclear and mitochondrial
genome expression in neurons. In summary, insights from the proposed experiments will significantly advance
our understanding of long-term of mitochondrial proteome homeostasis and genome integrity in neurons, which
could provide with new molecular targets for modulating the mitochondrial network dynamics in the processes
of neurodegeneration.

Public health relevance
Project Narrative Impaired mitochondrial function is a point of convergence for numerous neurological, neurodevelopmental, and neurodegenerative disorders. In this proposal we investigate newly discovered long-lived mitochondrial proteins that persist for months in the mammalian brain. The proposed research will elucidate novel aspects of mitochondrial biology and new avenues of research into the processes of age-related neurodegeneration and beyond.